Studies of Skin Microflora in Healthy Individuals and Atopic Dermatitis Patients

We continue to investigate and publish our findings on the microbiota in patients with atopic dermatitis and healthy individuals. We study bacterial, fungal, and viral components of the skin microbiome using amplicon and shotgun metagenomic sequencing. We continue to study the skin microbiome in patients with atopic dermatitis and with primary immunodeficiencies associated with dermatitis (including hyper-IgE syndromes), in addition to follow-up sampling visits from previously enrolled subjects. The sequencing for this project was initially funded by the National Institutes of Health Roadmap Project, The Human Microbiome Project. We continue to investigate the presence of bacteria, fungi, and viruses on skin, including Merkel cell polyomavirus which has been linked with Merkel Cell Carcinoma and Human Papillomaviruses and other microbiota in primary immunodeficiency patients before and after bone marrow transplantation.